Characterizing individual differences in the reciprocal relationship between sleep deprivation and binge drinking within the context of college life

Abstract
There is strong evidence that maladaptive behaviors, including poor sleep hygiene and binge drinking, emerge
in the college environment. When repeated in cycles, risk of habit development increases. This may contribute
to the development of addiction, psychiatric illness, and physical disease. Both chronic sleep deprivation and
frequent excessive alcohol use disrupt behavioral and physiological functioning, and their relationship appears
reciprocal. Research on individual differences in the alcohol-sleep relationship is largely unexplored, but may
identify putative biomarkers for immediate and long-term risks of alcohol misuse. This proposal's public health
significance stems from its potential to reduce immediate alcohol-related harms in college students and
develop scientific premise for improving the lives of individuals with sleep and alcohol use disorders. Proposed
studies build from an ongoing longitudinal study of college students (R01 AA027017), using its participants,
weekly drinking data, and physiological protocols. It maps the sleep-alcohol relationship onto individual
drinking bouts. It pairs self-reported sleep quality with objective measures of sleep behavior (actigraphy) and
physiology (polysomnography) that are collected before, during, and after a drinking bout. Sleep is
operationalized as a multidimensional and dynamic behavior that is measurable within and across discrete
episodes. Self-reported alcohol use and consequences are paired with a cardiovascular reactivity test that
objectively assesses proximal physiological repercussions of drinking. Study 1 (n= 150) is a one-week
actigraphy study of sleep duration, timing, and fragmentation. Aim 1 focuses on sleep behaviors preceding a
drinking event (i.e., pre-intoxication) and assesses how cumulative sleep debt and sleep irregularity influence
individual differences in the immediate consequences of drinking measured from self-report and cardiovascular
reactivity. Aim 2 targets sleep on the night of a drinking event (i.e., during intoxication) and assesses individual
differences in acute alcohol effects on sleep quantity and quality, as well as associations with alcohol use
behaviors across the subsequent week and over 2-years. Study 2 (n=25) involves at-home, overnight
polysomnography sessions on a night following a drinking night and on a night that does not follow drinking to
assess sleep architecture (e.g., time spent in rapid eye movement (REM) and slow-wave sleep) changes. Aim
3 explores how sleep is altered during recovery (i.e., post-intoxication) from drinking and if individual
differences in sleep physiology relate to sleep behavior and cardiovascular physiology. This application
innovates through its use of multi-level assessments of sleep and alcohol use; concurrently collecting objective
data may help dissociate contextual influences on self-report. It also innovates with a multi-PI design that
ensures primary expertise in both the alcohol and sleep fields. Added value for the proposed studies comes
from the resulting intensive, day-level, longitudinal data that has the potential to generate secondary analyses
focused on event-level data of within-subject alcohol-sleep relationships across time.

Public health relevance
Narrative College students often misuse alcohol and report poor sleep. These habits are solidified in young adulthood and can contribute to long-term mental and physical health issues. This proposal seeks to understand individual differences in how alcohol misuse and poor sleep interact to identify biomarkers that may reduce risk for alcohol use disorders and other related health conditions.